Resource Core

The overarching goal of the Resource Core is to make high quality data and expertise accessible to a broad
community of investigators interested in musculoskeletal research. To that end, we have two main aims: 1) to
provide access to data needed for musculoskeletal research, as well as the methodologic expertise and tools
to address the research questions at hand, and 2) to ensure that the data, services, and research products
maintained by the Resource Core are used by a broad range of investigators and the NIAMS research
community. The Resource Core supports access to a number of existing robust, ready-to-use musculoskeletal
research databases. It also will facilitate access to databases not specifically designed for musculoskeletal
research, to be harnessed for musculoskeletal research, such as MarketScan Claims data and Centers for
Medicare and Medicaid services data (CMS). These datasets provide a wide variety of data relevant to the
NIAMS mission of musculoskeletal research including imaging data, clinical data, and patient reported
outcomes. Further, the Resource Core will conduct analyses within the Center using these databases to
provide a pathway for CCCR investigators to conduct replication or external validation studies. The Resource
Core will actively promote the novel methodologic and biostatistical tools and “products” developed by the
Methodologic Core and Image Processing Group as well. The Resource Core will continue to (1) actively
engage researcher and clinician stakeholders to promote the use of data resources and services, and (2)
disseminate the research products developed by the Methodologic Core through channels that reach
researcher and clinician stakeholders. We will track the Core’s success using metrics that reflect the use of
Resource Core data, services, and research products, including the number of grants submitted and funded,
publications, and current projects. The Resource Core will also contribute to an Enrichment Program, led by
the Administrative Core, that includes Pilot and Feasibility awards for researchers likely to be NIAMS-funded in
the future, scientific webinars related to the Center’s resources and focus areas, and an annual Visiting
Scientist Program organized by the Methodologic Core.